Florida Registry for Aging Studies

ABSTRACT
Recruitment and retention of older African American [AA], Latino/Hispanic [LH], and Caribbean [CN] adults into
clinical research continues to be a significant challenge. Exploring younger family members' (25-64 years)
influence on recruiting older adults (65 years and older) into aging research is particularly important since
many culturally diverse adults consult family members when making healthcare treatment decisions.
Therefore, the focus of the current proposal is to understand how intergenerational influence (IGI) – the
influence of one generation on another in terms of the transfer of skills, attitudes, preferences, values, and
behaviors – can be leveraged to recruit and retain older diverse adults into clinical research. We use the
Theory of Reasoned Action (TRA) and IGI to guide our research. The primary goal is to have a population
of diverse older adults ready to participate in NIA funded clinical research studies. Specific aims of this
study are 1) to identify strategies that promote recruitment and enrollment of diverse older adults into aging
research; 2) implement a communication plan to increase awareness of and willingness to participate in
research and 3) implement a statewide registry of AA, LH and CN older adults ready to participate in NIA-
funded clinical research. To the best of our knowledge, this is among the first to propose an organized plan
specifically designed to increase our understanding of younger and older diverse adults' knowledge of
research participation, and then translate this information into a strategic plan to recruit and enroll older diverse
adults throughout Florida into a registry.

Public health relevance
Narrative Enrollment of culturally diverse older adults (African American, Latino/Hispanic and Caribbean) into aging research is important if we are to assure that the outcomes of clinical research is representative of the population. Thus, the focus of the current study is to increase our understanding of a) how intergenerational influences (influence of one generation on another) can be leveraged to increase clinical research participation of older diverse adults b) barriers and facilitators to research participation and c) what information diverse adults want to have when deciding whether to participate in clinical research. The research will also implement a registry of older adults who are engaged and ready to participate in aging research opportunities.